Roles of ion-channel mediated bioelectricity in developmental patterning

PROJECT SUMMARY
Embryogenesis from a fertilized egg into an individual is a precisely controlled process. One of the critical aspects
of embryogenesis is developmental patterning, which determines organ size and shape by orchestrating many
developmental and cellular events. Any abnormality from this patterning process will lead to congenital diseases
in humans. However, understanding the mechanisms that pattern embryos remains a central challenge in
developmental biology. The status quo of embryonic developmental patterning centers on the conceptual
framework that development is governed predominantly by morphogenetic proteins that activate transcription
factor networks in responding cells. The roles of bioelectricity in regulating embryonic developmental patterning
have just started to be recognized as a new mechanism of cellular signaling. Given many ion channels and
solute carriers are frequently involved in human congenital diseases, there is a critical need to understand ion
channel-mediated bioelectricity in developmental patterning. The lack of information about this bioelectric
patterning mechanism is a significant obstacle to understanding fundamental biological sciences and developing
therapeutic strategies for many human congenital diseases.
To address the demanding need, we will investigate the embryonic patterning mechanism of bioelectricity in the
zebrafish model using newly developed technologies for neuroscience, such as chemogenetic tools and
genetically encoded voltage indicators. Aim1. To elucidate the roles of bioelectricity in regulating zebrafish fin
patterning. Aim 2. To reveal the roles of bioelectricity in pigment cell patterning. With this long-studied pigment
system, we will further demonstrate bioelectricity as a general patterning mechanism in vertebrate
embryogenesis.
The expected outcomes will elucidate a less recognized developmental patterning mechanism by bioelectricity
in both zebrafish fin and skin pigment. This knowledge will establish a new concept for patterning in
developmental biology, provide the foundation for understanding vertebrate morphological diversity in evolution,
and principles for developing prevention or therapeutic strategies for congenital diseases.

Public health relevance
PROJECT NARRATIVE Human and animal organ size and shape are precisely controlled by a patterning process during embryonic development and individual growth. Our current knowledge about this patterning process is still limited. The outcome of this project will demonstrate a previously less recognized patterning mechanism by ion channel- mediated bioelectricity, and this knowledge could be used for developing preventive and therapeutic interventions of human congenital diseases in the future.